Pilot Project Program

Project Summary
Pilot Project Program
The Pilot Project Program for the Center of Integrative Neuroscience will continue to build a critical mass of
extramurally-funded investigators in neuroscience at the University of Nevada, Reno and facilitate access to
the research infrastructure provided through the Center’s four research core facilities. The program will achieve
this through two strategies. Pilot project funding will be provided to two junior neuroscience faculty each year to
develop research projects utilizing the core facilities. The project leaders will receive mentoring by a senior
expert in their area with a focus on acquiring the preliminary data from the pilot project to develop a submission
for extramural grant awards. The second strategy will be to provide small pilot awards for investigators within
the broader neuroscience and biomedical research community to support fees for using the facilities and
services in each of the cores. These awards will again be prioritized to allow investigators to acquire the data
needed for pursuing extramural funding. These programs will increase the user base and impact of the cores
for supporting both published research and grant funding, and will help continue to build the need and user
base for the cores that will allow them to transition to permanent supported facilities by the end of the COBRE
funding.

Public health relevance
Project Narrative Pilot Project Program The Pilot Project Program for the Center for Integrative Neuroscience will continue the funding and support for junior faculty and access to required research infrastructure to develop the University of Nevada’s research capacity to contribute to advances in the understanding of normal brain function and neural deficits.